DRC Transgenic and CRISPR Mouse Core

Summary
Diabetes research during the coming decades will depend heavily upon the ability to utilize the mouse as an
experimental model. Mouse models will be critical for investigating both basic and clinically relevant questions
in diabetes research. The strong conservation between the genomes of humans and mice, coupled with similar
aspects of their physiology, makes mice a powerful model system for understanding human diabetes. In
particular, the ability to alter the mouse genome as a means to create models for human diabetes, endocrine
pathologies, and diabetes complications will greatly facilitated diabetes research, particularly with regard to in
vivo aspects of diabetes. The Transgenic and CRISPR Mouse Core (TCMC) provides investigators at UCLA and
UCSD with a wide array of genetic manipulations in the mouse, including targeted deletions, insertions, and point
mutations. We use the most cutting-edge approaches, including various versions of the CRISPR system, to
performing reverse genetics in the mouse. In addition to small mutations, we perform large DNA replacements,
generate mice with conditional Tet-inducible and tamoxifen-inducible transgenes, and create tissue-specific and
conditional knock-out mice using Cre-LoxP and Flp recombinases and recombination–mediated cassette
exchange (RMCE). We also generate transgenic mice with BAC insertions, and create mice with specialized
properties, including BAC-Trap, RiboTag, and tagged-protein mice. The Core also provides other services,
including (i) cryogenic freezing of mouse sperm and embryos and (ii) in vitro fertilization to resuscitate mouse
sperm. Our long-standing Core is an impressive example of how specialized techniques, highly trained dedicated
personnel, specially constructed facilities, and state-of-the-art equipment can be accessed by researchers to
achieve goals not feasible on an individual basis.
Key objectives are:
1. To create innovative and important mouse models for studies of diabetes and its complications
2. To eliminate barriers to the most cutting-edge mouse genetic approaches for the DRC membership
3. To provide outstanding, reliable, and high-quality mouse embryology and genetic services
4. To advance the technology of genetic manipulation of the mouse genome
The availability of the TCMC in coordination with the other DRC Cores, will continue to enable our members to
conduct versatile, cutting-edge genetic research in the mouse with a battery of multidisciplinary, state-of-the-art
techniques.